ANIMAL FACILITY IMPROVEMENT AT NORTHWESTERN UNIVERSITY

Northwestern University proposes to accomplish physical plant modifications, replacement of ageing and obsolescent animal care equipment and purchase of animal care equipment items that will allow improvement of its animal resources so that it may continue to comply with all relevant guidelines, policies, laws, rules and regulations which relate to standards of research animal care.